Analysis of complex biological systems by high-throughput genomic technologies

Computational Biology & Genomics Core (CBGC) aims to advance aging research in NIA-IRP through the analysis of complex biological systems by high-throughput genomic technologies such as Next Generation Sequencing, Single Cell Sequencing, and microarrays. CBGC provides these services primarily to NIA intramural scientists and their collaborators. In addition, we collaborate directly with investigators in other NIH institutes as well as the extramural community. In fiscal year 2021 we completed sequencing of 320 samples and completed microarray hybridization of 72 RNA samples. The Computational Biology & Genomics Core (CBGC) provides advice on experimental design and sample preparation, quality control of samples, data analysis, data sharing, and training. Apart from the primary focus on genomic and transcriptomic research, CBGC is highly interested in applying Artificial Intelligence (AI) for image analysis and novel genomic data analysis algorithms. The core utilizes gene expression microarrays, Illumina and Oxford Nanopore sequencers and 10x Genomics single-cell analysis instruments to meet the needs of NIA IRP researchers. Moreover, CBGC maintains several high-performance computer systems and is involved in designing and maintaining NIA IRP cloud computing for use by all interested NIA IRP researchers.